Enhanced Mitochondrial Function Increases Effectiveness of Post-Stroke Rehabilitation

This project will investigate the efficacy of 2-hydroxypropyl-β-cyclodextrin (HPCD) in reducing stroke-induced
tissue loss and enhancing motor rehabilitative training after stroke. The proposed mechanism of action is the
removal of proinflammatory myelin lipid debris and the restoration of mitochondrial function in myeloid cells after
stroke. This is supported by our recent published studies that reveal that the processing and clearance of
cholesterol and other lipid debris derived from myelin drives a chronic inflammatory response in the focal
ischemic lesion of the sensorimotor cortex (SMC) in an experimental model of stroke. HPCD entraps and
solubilizes lipid debris, upregulates genes involved in lipid metabolism, and downregulates genes involved in
innate and adaptive immunity, reactive astrogliosis, and chemotaxis. Correspondingly, HPβCD reduces the
accumulation of lipid droplets and mitochondrial stress within myeloid cells in stroke infarcts. Repeated
administration of HPβCD also preserves neuronal immunoreactivity in the striatum, thalamus, and hippocampus.
Additional data reveals that HPβCD improves recovery through the protection of hippocampal-dependent spatial
working memory and by reducing impulsivity. These results indicate that systemic HPβCD treatment following
stroke attenuates chronic inflammation and secondary neurodegeneration. Therefore, we hypothesize that
treating mice with HPβCD after stroke and during rehabilitative training will improve motor outcomes in a mouse
model of sensorimotor stroke. To test this hypothesis, we will first optimize the dose using mitochondrial function
within myeloid cells, markers of inflammation and neurodegeneration, and cell type specific spatial
transcriptomics as functional readouts (Aim 1). We will then investigate the mechanism by which HPβCD
alleviates lipid build-up and mitochondrial dysfunction within myeloid cells (Aim 2). We will then determine the
extent to which our optimized dose enhances rehabilitative training induced behavioral improvements and brain
remodeling (Aim 3). Successful completion of these studies will reveal the dose, mechanism, and ability of
HPβCD to support rehabilitative training during recovery from stroke. Since HPβCD is an FDA approved
compound, successful completion of these studies in accordance with Stroke Therapy Academic Industry
Roundtable (STAIR) guidelines could rapidly lead to clinical trials for human stroke survivors.

Public health relevance
The goal of this study is to provide the foundation for a novel treatment approach for stroke—specifically, that enhancing mitochondrial function of immune cells can prevent the inflammation driven secondary neurodegeneration that occurs to tissue surrounding chronic stroke infarcts. This would improve recovery and the effectiveness of post-stroke rehabilitation and increase the long-term quality of life and cognitive function of individuals that have suffered from stroke.